Aging hippocampus and cognitive control in health and MCI

ABSTRACT/SUMMARY
Comprising proactive (goal-directed) and reactive (stimulus-driven) processes, cognitive control is critical to daily
functions for older adults. However, how aging influences proactive and reactive control remains unclear, with
studies of the AX-continuous performance task (AX-CPT) reporting impaired proactive but intact reactive control
and studies of the stop signal task (SST) reporting the opposite. Further, the structural and functional cerebral
bases of age-dependent changes in cognitive control have not been studied systematically. We aim to employ
an innovative experimental design to address this gap in research. On the basis of the literature and our
preliminary findings, we will investigate hippocampal dysfunction and impairment in contextual processing as a
determinant of cognitive control deficits during aging and in individuals with mild cognitive impairment (MCI).
Specifically, we aim to examine how contextual representation (i.e., explicit stimulus-response mapping in the
AX-CPT and implicit inference in the SST) rather than motor demand (i.e., omnipresent response in the AX-CPT
and conditional response in the SST) contribute to age-related deficits in cognitive control. By including two
variants of the behavioral tasks, the AXn-CPT, where non-target response is replaced with no response, and
SSTr, where stop signal instructs an alternative motor response instead of no response, we propose to
distinguish the psychological constructs that dictate age- and MCI-related changes in proactive and reactive
control. By combining the behavioral tasks and fMRI we will investigate how structural and functional brain
changes account for age- and MCI-related alterations in cognitive control. First, we hypothesize that, if contextual
representation accounts for the effects of aging and MCI, aging will be associated with impaired proactive and
intact reactive control in both AX-CPT and AXn-CPT, and with intact proactive and impaired reactive control in
both SST and SSTr. Conversely, if motor demand accounts for the effects, older adults will show impaired
proactive and intact reactive control in AX-CPT and SSTr, as well as intact proactive and impaired reactive
control in SST and AXn-CPT. Second, we hypothesize that deficient control is associated with disrupted
activation and functional connectivity in the hippocampus and other task-related regions. In particular, the
anterior and posterior hippocampus may play distinct roles in supporting reactive and proactive control. Third,
we hypothesize age-related decreases in hippocampal and prefrontal cortical gray matter volume and will explore
how this structural deficit relates to age-dependent alterations in functional activations during cognitive control.
Further, disproportionate volumetric decline and altered activations in the hippocampus may be associated with
deteriorated cognitive control in MCI. Together, the proposed study will delineate the psychological and neural
processes underlying executive control dysfunction in aging and MCI, addressing a critical gap of research in
aging neuroscience. We hope that the findings would inform the care of older adults in health and illness.

Public health relevance
PROJECT NARRATIVE Aging is associated with deficits in cognitive control, an executive function central to mental health. We propose new experiments to distinguish the psychological and neural processes underlying cognitive control dysfunction in older adults including those with mild cognitive impairment. The results will contribute to our understanding of the effects of aging on cognitive function and may help advance research of many age-related clinical conditions including Alzheimer’s disease.